CCDI SUPPORT FOR NIH/NCI/DCCPS SURVEILLANCE RESEARCH PROGRAM

Childhood Cancer Data Initiative (CCDI) support for this contract. This contract provides support for the activities related to: cancer data collection, quality control, analysis, dissemination of reliable population-based cancer statistics, geospatial data systems, statistical modeling and other novel methodological and technological solutions relevant to cancer surveillance.